Controlled release of RNA-targeting therapy to promote healing of diabetic ulcers

Project Summary
Non-healing ulcers are a common complication of diabetes, resulting in decreased quality of life, elevated rates
of amputation, increased risk of mortality, and high healthcare costs. Unfortunately, current treatments remain
outdated and inadequate. In diabetes, neuropathy and microvascular changes in dermal tissue lead to
dysregulated molecular cues, resulting in chronic inflammation and reduced angiogenesis that prevent wound
healing. Poor angiogenesis is particularly critical given the importance of vasculature in supplying oxygen,
nutrients, and systemic signaling molecules. Impairment of angiogenesis is in part driven by aberrant expression
of coding messenger RNAs (mRNAs) and non-coding microRNAs (miRNAs) at various time scales. Thus, one
promising approach to alter the course of diabetic ulcers is to directly target the expression of upregulated RNAs
in the non-healing state using nucleic acid RNA-targeting therapies; however, delivery challenges render nucleic
acid therapies clinically unfeasible. To address these delivery challenges, the Hammond Lab has developed and
demonstrated self-assembled electrostatic deposition of nucleic acids through the layer by layer (LbL) technique,
which leverages iterative adsorption of polyelectrolytes of alternating charge, to create conformal coatings on
wound bandages with tunable release kinetics. I propose to develop and investigate temporally controlled
release strategies to locally deliver RNA-targeting therapies that promote angiogenesis and healing of
diabetic ulcers. In Aim 1, I will formulate staged release RNA-targeting bandages to promote wound healing
since staged release of therapy for multiple targets will allow the bandages to address different phases of wound
healing. A proof-of-concept bandage will be developed to elute RNA-targeting therapy to stimulate angiogenesis
in both the inflammatory and proliferative wound healing phases, and it will be tested for efficacy in vitro and in
a murine in vivo diabetic ulcer model. In Aim 2, I will identify potential synergies of pro-angiogenic anti-miRs
(miRNA inhibitors), as inhibition of gene expression with anti-miRs enables regulation of many genes along
defined tissue-specific signaling pathways to enhance angiogenesis. Since it is also unknown how delivery timing
of these anti-miR combinations may impact efficacy, we will leverage controlled-release LbL bandages to
investigate this. Through this research, I will advance the delivery of nucleic acids with biomaterial systems and
the targeting of aberrantly expressed coding and non-coding RNAs to promote healing of diabetic wounds. This
work will lay the groundwork for expansion of this platform approach to other diseases of impaired tissue
regeneration where timing the delivery to the healing process is critical, such as venous ulcers, mesenteric
ischemia, and myocardial infarction.

Public health relevance
Project Narrative Diabetic ulcers are non-healing wounds that pose significant challenges to many patients by decreasing quality of life, increasing mortality, and raising healthcare costs, yet current treatments do not enable ulcer closure or prevent ulcer recurrence in most patients. The proposed project will engineer local, timed delivery of combinations of therapeutics in order to alter the wound environment and promote the healing of ulcers. This research could improve clinical outcomes for patients with diabetic ulcers and provide broader insights into delivering therapies at specific time scales, improving treatments for other diseases of impaired tissue regeneration where timing delivery of the therapy is critical to its effectiveness.